Self-Monitoring Support Application for Adults with Diabetes and Hypertension

PROJECT SUMMARY/ABSTRACT
The purpose of this project is to develop a theory-drien, voice-activated, scalable, mHealth intervention to
promote self-management and patient-provider communication in patients with coexisting diabetes (DM) and
hypertension (HTN). Among the 30 million Americans who have DM, more than 20 million also have HTN. Self-
management of chronic conditions is a promising strategy for preventing the development of additional co-
occurring diseases and resulting in reduced morbidity and mortality. Self-monitoring health indicators (e.g., blood
pressure [BP], glucose) is a key component of successful self-management. Through self-monitoring, patients
can recognize patterns in their health indicators, obtain more health information, and change health behaviors.
To meet the self-management needs of individuals with comorbid DM and HTN, we propose to develop
a voice-activated self-monitoring (VoiS) support application on a smart speaker platform that includes three types
of fearues 1) self-monitoring features, including voice-activated data entry (i.e., glucose and BP), smart notes to
record lifestyle-related episodes that could result in unusual values of biomarkers, and smart speech reminders;
2) clinical decision support features, including an evidence-based knowledge base with AI engine for DM and for
HTN, and 3) shared decision-making features, including visualization of patient data on multiple platforms and an
audio briefing of patient data on a smart speaker.
We hypothesize that patients with coexisting DM and HTN will use the convenient VoiS app for routine
self-monitoring of biomarkers and for recording lifestyle-related episodes. Other hypotheses are: (1) the
synthesized patient data produced by the VoiS app will help patients better understand the status of their
conditions; and (2) patient-generated data-sharing via the VoiS app will help patients and providers effectively
communicate with each other, set shared goals, and choose personalized care plans to promote adherence to
treatment.
Before we can verify the clinical efficacy of this theory-based mHealth self-management intervention, we
first need to develop the VoiS. Therefore, aims of this study are to 1) develop the VoiS app including the three
features; and 2) test acceptability and usability of the VoiS app in the lab and in the field by patients with
coexisting DM and HTN. Findings from this project will enhance our understanding of user-perceived acceptance,
usability, and satisfaction with the VoiS app. Additionally, findings will be used to generate another R21
application to move this research forward through pilot testing to determine preliminary clinical efficacy using a
randomized design. We anticipate that this project will contribute to reduce racial and socioeconomic disparities
in self-monitoring and outcomes for patients with DM and HTN that are indicated by delayed access to care; and
inform the replication of this work for other coexisting metabolilc chronic conditions.

Public health relevance
PROJECT NARRATIVE Patients who routinely self-monitor their health indicators can better recognize patterns in their health indicators, obtain additional health information, and change their health behavior; however, patients with both diabetes and hypertension have difficulty self-monitoring health indicators routinely and understanding the meaning of indicators accurately. This project aims to develop a voice-activated theory-driven self-monitoring support application to help adults with both diabetes and hypertension to better self-manage their health conditions using intelligent technologies with features such as voice-activated data input and output, smart reminders, and visual and audio representations of data using medical/lay terminologies translation. We anticipate this application will serve as the infrastructure through which interventions can be designed and delivered to increase patient self- efficacy to monitor health indicators routinely and enhance patient/provider communication effectively by sharing patient-generated data.